PHASE I OF ALL-TRANS RETINOIC ACID IN SOLID TUMORS ON AN INTERMITTENT SCHEDULE

Assess pharmacokinetics and toxicities of All-Trans Retinoic acid and to assess whether an intermittent schedule will prevent the progressive decrease of TRA plasmal levels seen with chronic administration.